National Jewish Health CoFAR Clinical Research Unit

Project Summary/Abstract
This application is being submitted in response to RFA-AI-15-051, Consortium for Food Allergy Research
(CoFAR): Clinical Research Units (UM1). The goal of this proposal is to establish an infrastructure and clinical
strategies to prevent and manage food allergy (FA). Our central hypothesis is that prevention of skin barrier
dysfunction and atopic dermatitis (AD) complicated by Staphylococcus aureus infection using a linoleic acid
containing sunflower seed oil with anti-inflammatory, anti-microbial, and skin barrier enhancing properties will
prevent early skin allergen exposure and thereby prevent the occurrence of FA at two years of age. We will
achieve our objectives with the following aims:
· Specific Aim 1: To establish an Administration and Operations Element that will be responsible for
implementation of clinical trials and studies for the Consortium in the areas of prevention and treatment of
FA as well as an understanding of its underlying mechanisms. The Clinical Research Unit will also provide
an environment for New and Early Stage Investigators to develop research skills and assist them in
progressing to more senior status through their work in CoFAR.
· Specific Aim 2: To perform a Clinical Trial to determine if prevention of skin barrier dysfunction, AD and S.
aureus colonization using linoleic acid containing sunflower seed oil will reduce the occurrence of FA in a
prospective, randomized, controlled clinical Birth Cohort study of individuals at high risk vs. low risk of
atopy. The primary clinical hypothesis is that introduction of a linoleic acid containing sunflower seed oil
from birth will prevent systemic IgE allergen sensitization and clinical FA commonly associated with AD
(e.g. egg, milk, peanut, soy, wheat, tree nuts and others).
· Specific Aim 3: To determine if prevention of AD and S. aureus colonization using a linoleic acid
containing sunflower seed oil will reduce the occurrence of persistent FA and respiratory allergy later in
childhood. This secondary clinical hypothesis is that introduction of a linoleic acid containing sunflower
seed oil will reduce the occurrence of persistent FA as well as sensitization to environmental allergies and
asthma which is known to be associated with more severe food allergic reactions and anaphylaxis.
This clinical Birth Cohort Study will provide a framework for establishment of a data and biological specimen
repository (specific aim 4) to allow future studies of the role of skin barrier function and pathogenic
mechanisms related to FA.

Public health relevance
Project Narrative The goal of this proposal is to establish clinical strategies to prevent and manage food allergy. We propose to determine the occurrence of food allergy in a multi-center, controlled clinical study of systematic skin care from birth compared to infants without systematic skin care. Our central hypothesis is that prevention of skin barrier dysfunction will prevent early food allergen exposure through the skin and thereby prevent the occurrence of food allergy.